Engineering the Immune Response of a Self-replicating and Adjuvanting RNA HIV-1Vaccine

Project Summary/Abstract
A key requirement for HIV-1 vaccine development is the induction of broadly neutralizing antibodies (bNAbs)
targeting the HIV-1 envelope (Env) spike. The BG505 SOSIP.664 gp140 soluble timer is engineered to display
conformational epitopes recognized by several bNAbs but not non-neutralizing antibodies. The prototype SOSIP
vaccine is currently being evaluated in two clinical trials. An effective messenger RNA (mRNA) vaccine
expressing BG505 SOSIP.664 will complement the clinical vaccine and open a path to heterologous
immunization strategies to elicit immune responses defined by increased breadth and magnitude. Recent
achievements in mRNA vaccines is a result of advancements in nanoparticle delivery technologies. We recently
reported immunogenicity of a replicating RNA (repRNA) vaccine encoding the spike (S) protein of SARS-CoV-
2; this vaccine, delivered with a novel Lipid Inorganic Nanoparticle (LION) carrier, induced potent binding and
neutralizing antibodies in both mice and non-human primates. In the proposed R61/R33 application, we will
investigate and optimize attributes of the LION formulation to engineer the immunity of a BG505 SOSIP.664
expressing repRNA vaccine (repRNA-SOSIP.664). The goal is to identify a lead vaccine and administration route
that promotes B cell differentiation and maturation needed for induction of high affinity Env antibodies that confer
protection in a macaque SHIV challenge model. The proposed work will be performed with a three-way
collaboration between Dr. Amit Khandhar at HDT Bio, Dr. Noah Sather at Seattle Children’s Research Institute
(SCRI) and Prof. Deborah Fuller at the University of Washington (UW). Proposed activities in the R61 phase will
include (specific aim 1) optimizing the repRNA/LION platform for intramuscular (IM), intradermal (ID) and
intranasal (IN) delivery and (specific aim 2) screening immunogenicity of vaccine candidates in mouse and
rabbit models. In the R33 phase, we will advance (specific aim 3) one or more lead vaccine candidates to
evaluate protective efficacy in a macaque SHIV challenge model. Milestones in the R61 phase are (milestone
1) identification of formulations that target lymph nodes or remain at injection site, (milestone 2) develop an
optimized LION formulation for intranasal delivery of repRNA, (milestone 3) one or more repRNA/LION
immunization regimens that induce neutralizing antibodies greater than or equal to the BG505 SOSIP.664
protein/adjuvant vaccine. Using clearly defined go/no-go metrics for each milestone we will determine transition
to the R33 phase of the project. Milestones in the R33 phase are (milestone 1) one or more vaccine regiment
affords statistically significant protection compared to controls in a macaque SHIV challenge model as measured
by one or more protection measures and (milestone 2) one or more immune responses in vaccinated animals
correlate with one or more protection measure.

Public health relevance
Project narrative The prototypic BG505 SOSIP.664 protein is a potent HIV-1 immunogen currently in two phase I clinical trials. RNA vaccines induce immune pathways distinct from protein-based vaccines, and if successfully developed, our proposed replicating RNA (repRNA) vaccine can complement the clinical vaccine and potentially boost waning immune responses. We will develop a repRNA vaccine expressing BG505 SOSIP.664 and evaluate protective immunity in a non-human primate challenge model.